Nest#3-Wearable Interoperable Neuroprosthesis Gear (WING)

This WING Nest project will develop external components necessary for developing new
COSMIIC modules, recharging the implanted power supply, programming the implanted
COSMIIC system, as well as integrating the implanted system with external sensors and surface
stimulation. These deliverables will lower the cost and risks of developing implanted bioelectric
interventions and enable the broader community to rapidly develop closed-loop neurostimulation
interventions based on physiological signals. The first objective is to develop a Wireless Link
that will connect PCs, mobile devices, and sensors to the implanted system. This wireless link
will facilitate wired or wireless communication between the COSMIIC implanted modules and
computers used to program the modules. It will be compatible with common wired and wireless
sensor communication protocols. Using the Wireless Link will facilitate closed-loop stimulation in
response to physiological signals or smartphone app interactions. The second objective is to
develop a Surface Stimulation module that is battery-powered and delivers four channels of
stimulation. Skin surface electrical stimulation is low-risk and convenient for prototyping new
stimulation functions. The third objective is to develop a benchtop circuit board Evaluation Kit for
the implanted COSMIIC modules. This kit will facilitate custom COSMIIC module development
by allowing the custom circuit boards to function prior to development of costly titanium
enclosures or implant-grade leads. Circuit board frames will be developed that supply network,
power, and provide access to useful debugging connections. The fourth objective is to develop
a rapid inductive battery charger for the implanted COSMIIC system. The charger will optimize
charging time by adjusting active cooling and current flow based on battery status.